Addressing sleep health disparities from within: A community-engaged study to understanding sleep and cardiometabolic disease risk among women of color

Abstract
Women of color have increased rates of cardiometabolic disorders (e.g., cardiovascular disease, diabetes,
hypertension). Although epidemiologic studies demonstrate short sleep duration and poor sleep quality
increase cardiometabolic disease risk, few studies have examined mechanisms of short sleep duration and
poor sleep quality from the perspectives of women of color. This project builds on our team’s collaboration with
Community Faces of Utah, an organization that links the University of Utah and Utah Department of Health
with four local communities of color (Black/African American, Hispanic/Latinx, Native Hawaiian/Pacific Islander
and African Immigrant/Refugee). Our team previously completed a 12-month community health worker (CHW)
delivered wellness intervention in 485 women that improved diet and physical activity; however, results
indicated sleep was an unmet need (41% reported sleep duration <7 hours but only 12% were interested in
sleep improvement). Our results and others suggest that more research is needed to understand how sleep is
traded off for other responsibilities and demands in the lives of women of color. To address this gap, we are
proposing a community engaged mixed-methods study to advance the understanding of how time use
affects sleep and cardiometabolic disease risk among women of color. Our study will utilize a 3-step
process: In Aim 1, we will begin by collecting qualitative data (focus groups) among CHWs for an in-depth
understanding of how women balance sleep and other demands, both from their perspectives as community
members and as trusted front-line public-health workers; In Aim 2, we will utilize results from the focus groups
to conduct a field study among 400 women of color from the four participating communities to examine the
relationships between time use, sleep, diet, physical activity, and cardiometabolic health and use innovative
statistical modeling techniques to understand the impact of time trade-offs on sleep and cardiometabolic
health; and in Aim 3, we will use an intervention mapping framework to integrate the results of the focus groups
and field study, and plan the next step interventions with our community advisory board. This study is
innovative in exploration of an understudied mechanism in sleep, evaluation of sleep health in populations
often not included in sleep research (Native Hawaiians/Pacific Islanders, African Immigrant/ Refugees), and in
our collaboration with CHWs, front-line public health workers who are underutilized in sleep research. Our
long-standing partnerships support feasibility, usefulness to the community and our ability to rapidly translate
results into interventions to improve sleep and cardiometabolic disease risk among women of color.

Public health relevance
Project Narrative Women of color have increased prevalence of short sleep duration and poor sleep quality, which increases risk for cardiometabolic disorders such as diabetes and high blood pressure. The results of this community- engaged project conducted among women from the Black/African American, Hispanic/Latinx, Native Hawaiian/Pacific Islander and African Immigrant/Refugee communities will increase our understanding of women’s time use and how the relationships between time spent for sleep, physical activity and other demands affect risk for cardiometabolic disease. Study findings will result in novel interventions to improve the sleep and health of women of color.